Integrative metabolomics of bronchopulmonary dysplasia in extremely low gestational age infants

PROJECT SUMMARY/ABSTRACT
Bronchopulmonary dysplasia (BPD) in preterm infants is a common and often severe lung disease with long
term sequelae. Rates of BPD vary between racial/ethnic groups, which may be due to differences in genetic
ancestry or environment factors. Changes in the biochemical composition of biofluids (the metabolome) reflect
the sum of both genetics and the environment, and thus characterizing these changes offers a broader view of
the disease process as compared to genetic studies alone. Our goal is to increase our understanding of the
biological basis of BPD and response to interventions in genetically diverse preterm infants at high risk of dis-
ease. We hypothesize that there are temporal changes in the urinary and tracheal aspirate (TA) metabolome of
the premature infant that are associated with respiratory outcomes and interventions, and that some of these
changes vary by infant genetic ancestry. We will test our hypothesis with three specific aims. Specific Aim 1:
Longitudinal characterization of the urinary and lung fluid metabolome of preterm infants. We will
measure longitudinal changes in metabolic profiles of urine and tracheal aspirates in two cohorts of preterm
infants at high risk of BPD from three racial/ethnic groups. We will identify changes in the metabolome of
infants that are associated with respiratory status (diagnosis of BPD and later respiratory outcomes) and inter-
ventions (e.g. type of nutrition, iNO therapy, corticosteroids, and other medications). Results from this aim will
provide new information on the biofluid metabolome of preterm infants, biomarkers of disease and response to
interventions, and insight into postnatal lung development and disease pathogenesis. Specific Aim 2:
Examine the contribution of genetic ancestry, race and ethnicity on longitudinal changes in the biofluid
metabolome of preterm infants. We will investigate the contribution of genetic ancestry and maternal self-
reported race/ethnicity on temporal changes in the biofluid metabolome of premature infants. We will identify
metabolites and pathways whose trajectories are associated with genomic ancestry independent of maternal
race/ethnicity, and identify those under stronger genetic vs. social/ environmental determination. Results from
this aim will provide new information as to the role of genetics on the biofluid metabolome of preterm infants as
it relates to racial/ethnic differences in BPD and response to interventions. Specific Aim 3: Integrate genomic
and metabolomic studies of BPD. We will identify novel metabolite quantitative trait loci (mQTL) in high risk
preterm infants using a two-step approach that leverages variation in local genetic ancestry, and develop a
resource to empower multi-omic studies of BPD. We will then combine this information with a genome-wide
association study (GWAS) of BPD by integrating metabolomic and genomic associations in the same infants to
identify novel genetic loci and biochemical pathways involved in the development and pathogenesis of BPD.
Relevance: Results from this proposal will advance our understanding of disease pathogenesis in high risk
preterm infants, and support the development of biomarkers and precision-targeted therapies.

Public health relevance
PROJECT NARRATIVE Bronchopulmonary dysplasia (BPD) in preterm infants is a common and often severe lung disease with long term sequelae. Currently, there are no biological markers available to predict which infants will develop BPD or to assess options for prevention and treatment. The goal of this project is to characterize infant physiology using metabolomics, and to investigate the role of race/ethnicity, genetics and medical interventions in order to increase our knowledge of the biological basis of BPD and improve the health and outcome of these infants.